Project 2: Orexin Signaling and Hypoventilation

PROJECT SUMMARY
This Project focuses on improving breathing in mouse models of Obesity Hypoventilation syndrome (OHS)
and Opioid-Induced Respiratory Depression (OIRD) as these disorders are relatively common causes of
hypoventilation and have very high mortality. OHS occurs in people with severe obesity and is manifest as
hypoventilation during wakefulness and especially during sleep. Opiates also reduce ventilation, and about 6%
of Americans take prescription opioids which can cause hypoventilation and worsen sleep apnea and other
respiratory disorders. Considering these staggering impacts, there is a large and unmet need to develop better
therapies for these hypoventilation disorders.
Several lines of evidence indicate that increasing orexin signaling through the orexin receptors should be a
highly effective therapy for people with OHS and OIRD. The orexin neurons excite all key brainstem regions
regulating ventilation. In addition, orexin knockout mice have a blunted response to hypercarbia, and orexin
receptor antagonists reduce the response to hypercarbia. We hypothesize that increased activity of the orexin
neurons and orexin agonists will improve breathing in mouse models of OHS and OIRD via lower brainstem
respiratory circuits. As a model of OHS, we will use mice with diet-induced obesity which are severely obese
and have hypoventilation with a reduced hypercapnic ventilatory response. In addition, we will study mice
treated with morphine as a model of OIRD.
These Aims seek to determine the role of orexin signaling in the responses to hypercapnia and OIRD. This
Project synergizes well with Projects 1, 3, and 4 that seek to enhance ventilatory responses to hypercapnia
and OIRD in mice, and Project 5 which seeks to identify pharmacological methods to improve hypoventilation
in people, especially with OIRD. The first Aim is to determine if the orexin neurons are necessary for the HCVR
and OIRD with morphine in a novel mouse model. Second, we will define the location and molecular identity of
orexin-responsive neurons in the brainstem using in situ hybridization, calcium imaging and RNAseq, in
collaboration with the Electrophysiology and Molecular Biology Cores. The third Aim is to test if the orexin
neurons are sufficient to improve the response to hypercapnia and OIRD. Finally, we will test of an orexin
agonist improves the HCVR and OIRD and then map the brainstem regions through which this occurs.
Collectively, these experiments should demonstrate that orexin signaling improves hypoventilation in mouse
models of OHS and OIRD, and that orexin agonists have potential for improving these disorders.